Center of Biomedical Research Excellence in Acute Care Research and Rural Disparities

Project Summary
Rural outcomes following high acuity, low occurrence (HALO) conditions are suboptimal. During
resuscitation of neonates, a HALO event, rapid access to appropriately equipped and trained medical
personnel capable of delivering time-sensitive medical interventions is essential, or the consequences
are dire, including mortality and significant morbidity. The Neonatal Resuscitation Program (NRP®), a
national guideline and training program, designed to standardize care and improve adherence to care
algorithms, is delivered every two years. However, knowledge and technical skills involved in
adherence to best practices typically degrade over two to three months if the skills are not used
clinically. For high-volume, urban teaching hospitals, there is sufficient volume to maintain skills. For
lower volume rural and community hospitals, there is a lack of opportunities to maintain skills,
including Maine, where neonatal resuscitation is a true HALO event with the vast majority of hospitals
delivering less than one infant a day and very few newborns needing any resuscitation. High volume
centers across various populations have better outcomes, and in emergencies, patients in lower
volume centers experience higher rates of medication errorsand differences in adherence to care
algorithms. Studies estimate that 20-40% of neonatal lives could be saved with proper neonatal
resuscitation and are dependent upon a rapid, knowledgeable, and skillful response. There is an
urgent need to increase rural community hospital readiness and solutions to improve neonatal HALO
related care delivery. The overall goal of the parent grant, the NIH COBRE in Acute Care Research
and Rural Disparities, is to support and develop strategies to reduce health disparities due to rurality.
This supplement grant proposal seeks to decrease the healthcare disparities experienced by rural
patients by targeting team-based performance training for neonatal resuscitation. We aim to conduct
a pilot crossover study comparing team performance in NRP®, teamwork, and communication skills
with HoloBabyTM (a novel mixed reality neonatal manikin prototype) and HiFi manikin simulation. We
will compare team performance in simulations using HoloBabyTM and HiFi training. Simulations will be
video recorded and investigators will rate NRP® adherence, teamwork, and communication using
standardized scoring tools. We hypothesize teams’ performance with the different simulation
technologies will be equivalent. We also aim to evaluate the psychometric properties of the modified
NRP® adherence assessment tool. We will use data collected in Aim 1, in addition to existing
assessment data, to examine estimates of reliability and validity for the NRP® assessment tool. We
hypothesize the modified NRP® assessment tool is a sufficiently valid and reliable tool for measuring
team performance in the simulated environment and will not differ according to simulator type.
To achieve our proposed aims, a diverse skill set, expertise, and team approach will be essential.
This project aims to leverage simulation expertise, including the neonatal simulation expertise of Drs.
Zanno and Melendi and the pediatric simulation experience of Dr. Mallory. The project will utilize
simulation expertise through the Hannaford Center for Safety, Innovation, and Simulation (HCSIS), a
high throughput simulation center for MaineHealth that reaches approximately 5,000 clinicians per
year across Maine. Dr. Strout has extensive training and experience in the conduct of clinical and
educational research across the lifespan, which includes qualitative, quantitative, and mixed
methodologies as well as psychometrics and measure development and evaluation. Together, this
team is poised to successfully achieve the aims proposed here, advancing scientific understanding in
this area and improving neonatal care delivery in rural communities.

Public health relevance
Project Narrative For medical emergencies, every second matters, and despite attempts to train and standardize rural clinicians to employ best practices for high acuity, low occurrence (HALO) events, such as cardiac arrest, it is well-described that patients have worse outcomes in rural community hospitals than in urban hospitals. Using two different simulation technology modalities for neonatal resuscitation, a HALO event, our project will compare adherence to Newborn Resuscitation Program (NRP®) guidelines, teamwork, and communication and evaluate the psychometric properties of the modified NRP® adherence assessment tool when used in our rural telesimulation training program. This study will refine the HoloBabyTM, a mixed-reality simulation prototype, and provide validity data to an NRP® adherence assessment tool, which can be used for evaluation of performance to provide feedback in simulated and real resuscitation scenarios, improving care delivery in rural areas.